The Gut-Liver Axis in HIV-Related Non-Alcoholic Fatty Liver Disease

Project Summary/Abstract
Liver disease is a leading cause of mortality in persons with HIV (PWH), and PWH suffer a disproportionate
burden of non-alcoholic fatty liver disease (NAFLD). While the mechanisms underlying this disparity are not
well understood, intestinal dysbiosis and intestinal barrier dysfunction are implicated in the pathogenesis of
NAFLD in HIV-negative persons. HIV infection has been shown to alter the intestinal microbiome, change the
plasma metabolome and impair intestinal barrier function; however, there are few data on the microbiome and
metabolome among PWH with NAFLD. My pilot preliminary data show that hepatic steatosis is associated with
differences in the intestinal bacterial community (reduction in butyrate-producing bacteria), bacteria-related
metabolites (including phosphatidylcholine), and markers of intestinal barrier dysfunction among PWH on long-
term ART. I hypothesize that intestinal dysbiosis in PWH promotes NAFLD through 1) impairment of intestinal
barrier function and 2) alteration of the plasma metabolome to promote hepatic lipid deposition. In Aim 1 I will
determine whether differences in plasma levels of NAFLD- and bacteria-related metabolites, including
phosphatidylcholine and trimethylamine N-oxide, are associated with hepatic steatosis in PWH. In Aim 2 I will
determine whether decreased abundance of butyrate-producing gut bacteria and markers of impaired intestinal
barrier function are associated with hepatic steatosis in PWH. In Aim 3 I will test the feasibility and limited
efficacy of a multi-strain probiotic and prebiotic fiber on NAFLD biomarkers in a prospective trial in PWH. Aims
1 and 2 will leverage existing data and specimens from 134 PWH in the NIH-supported HIV, Adipose Tissue
Immunology and Metabolism (HATIM) cohort, which includes metabolomic, microbiome, and imaging studies
from participants with a spectrum of metabolic fitness and in the absence of viral hepatitis or excessive alcohol
use. Secondary analyses will compare the findings from the HATIM cohort with both HIV-negative controls and
PWH with viral hepatitis and heavy alcohol use. The Aim 3 pilot trial will leverage the well-developed
infrastructure and large recruitment pool of the Tennessee Center for AIDS Research. Collectively, these Aims
address the call for research related to HIV-associated comorbidities, coinfections and complications described
in NIH Strategic Plan for HIV and HIV-related Research, and have the potential to inform new microbiome-
based diagnostics and treatments that will reduce the burden of NAFLD in PWH. My research and training plan
will be supported a multi-disciplinary team of scientists who have a strong record of mentoring young
investigators and the world-class training environment and resources available at Vanderbilt University Medical
Center. In addition to the benefits to the health of PWH, the proposed K23 studies and training plan will allow
me to further my expertise in patient-facing research and generate the data and publication track record
necessary to develop a self-sustaining research career in the field of HIV-related liver disease.

Public health relevance
Narrative Persons with human immunodeficiency virus (HIV) have higher risk of developing fatty liver disease (NAFLD) than HIV-negative persons but the reasons for this discrepancy are not known. Changes in the intestinal microbiome may contribute to the development of NAFLD in persons with HIV (PWH) through impairment of barrier function of the intestinal wall and by producing metabolites that are harmful to the liver. This project will test the hypothesis that HIV-related NAFLD is associated with differences in the intestinal microbiome and that supplementation with probiotic and prebiotic fiber will lead to improvements in markers of NAFLD in PWH.